CYCLOSPORINE A IN NEWLY DIAGNOSED INSULIN DEPENDENT DIABETES MELLITUS

A randomized trial of the effects of cyclosporina A over a four month period on insulin requirements in new onset type I diabetes in children.